Administrative Core

ABSTRACT ADMINISTRATION CORE
The Administrative Core will support the scientific and programmatic activities of our IPCAVD
Program and provide the necessary infrastructure for the Program to achieve its overall
research objectives and milestones in the most efficient and effective manner. This Core has
the following specific aims: (1) to provide scientific leadership and coordination of the IPCAVD’s
activities, assuring achievement of our scientific goals while maximizing scientific collaboration;
(2) to optimize communication among the participating Scientific and Clinical investigators;
between Project Leaders, the external Scientific Advisory Board, the NIAID and our Clinical
Partners; and (3) to provide fiscal oversight, administrative support, and ensure regulatory and
grant policy compliance. It will be led by the Principal Investigator, Dr. Leonidas Stamatatos,
who will manage, oversee and coordinate the efforts of each participant in the Program, with the
assistance of the Project Manager, Dr. Mingchao Shen. A group of external Scientific Advisors
will be formed to oversee the scientific activities of the IPCAVD and provide advice and support.
This Core will oversee and integrate the execution of the Research Plans, Product Development
Plan, and Clinical Development Plan. This Core oversees all aspects of this Program including
scientific issues, regulatory affairs, finance, communication, coordination and administration of
each of the Cores and Projects. This Core will ensure that expenditures and projections are
commensurate with the goals of the overall project; monitor the fiscal and functional aspects of
all subcontracts; and coordinate with the Offices of Sponsored Research at participating
Institutions for the disbursement, expenditure and accounting of grant funds. This Core will
coordinate the preparation and submission of scientific and financial reports, facilitate the
establishment of regulatory protocols and ensure regulatory compliance. Communications will
be facilitated utilizing a variety of tools, including a dedicated, external IPCAVD SharePoint site,
which will serve as a centralized repository for Program data, regulatory compliance documents,
inter-institutional and material transfer agreements and relevant publications, abstracts and
presentations.